Chronic Hypertension and Pregnancy (CHAP)

The agreement is to provide funds to the VA Clinical Research Pharmacy Coordinating Center, who will assist NIH/NHLBI with the Chronic Hypertension and Pregnancy grant. The VA will provide the services necessary to conduct clinical trials.